Administrative Core

Administrative Core
John Krystal, M.D.
Abstract
The Center for the Translational Neuroscience of Alcoholism (CTNA) places a high priority on maintaining an
efficient flow of information to promote the safe and successful completion of proposed studies, to support the
initiation of novel pilot studies, to facilitate the career development of trainees and junior faculty affiliated with
the Center, and to promote the dissemination of research advances. However, the CTNA views its mission as
"translational" in that it places a high priority on the interplay between basic and clinical neuroscience. Thus, its
administrative, monitoring, and educational components include representation from basic and clinical
neuroscience, and an essential charge of these is to preserve the integrity of the translational mission. The
Administrative Core provides for the centralized organizational functions of the Center for the Translational
Neuroscience of Alcoholism (CTNA). These functions include 1) the central executive function of the Center
(Director, Steering Committee), 2) financial oversight, 3) data safety monitoring (Data Safety Monitoring
Board), 4) educational functions (Education Committee), 5) and external ongoing review of the scientific merit
of CTNA activities (Program Advisory Committee).